SCH: Using Data-Driven Computational Biomechanics to Disentangle Brain Structural Commonality, Variability, and Abnormality in ASD

Autism spectrum disorder (ASD) affects up to 1% of children in the United States, resulting in significant
lifelong disability for the majority of those affected. Prior neuroimaging studies are limited to groupwise
analysis between ASD and controls, which cannot differentiate or disentangle cortical abnormality from
variability for a specific ASD subject. These difficulties originate from a lack of a novel brain structural
descriptor that can effectively represent the human brain architectures of each individual and extract brain
structural commonalities across individuals. Meanwhile, prior studies have demonstrated that mechanical
factors play important roles in the formation of brain architecture, including abnormalities observed in ASD.
Current brain mechanical models build upon simplified models with a focus on one specific mechanical
effort, but fail to explicitly capture the physical complexity of brain models and the interplay of multiple
mechanical factors simultaneously. This lack of knowledge is a crucial barrier to developing unbiased
models to understand the brain structural commonalities across individuals, as well as models that can
pinpoint the abnormalities in individual ASD brain. The overall objective of this research is to construct a
transformative brain structural network (BSN) for each individual brain, disentangle BSN’s commonality and
variability across individual health brains, discover the role of mechanics on the BSN’s commonality and
variability across individuals via imaging analyses and data-driven computational simulations, and pinpoint
cortical abnormality and evaluate their relevant impact in ASD brains by comparing BSN between ASD and
healthy brains. Our central hypothesis is that the brain structural network and its underlying mechanical
principles can be interpreted through a data-driven discovery of preserved, descriptive, universal, and
evident brain structural descriptor across individuals. The goal of the proposed work will be achieved by
completing the following three specific aims: (1) we will reconstruct individual cortical surfaces to identify
and assess 3-hinge gyral junctions (3HGs) and 3HG-based brain structural network and therefore examine
brain structure commonality across individual brains; (2) we will construct data-driven fetal whole brain
models, perform massive simulations with varying mechanical conditions, and collect data for machine-learning analysis; (3) we will evaluate brain structural network’s abnormality in ASD by conducting
comparison analysis with health brain and pinpoint mechanical factors that lead to this abnormality across
individuals.

Public health relevance
The goal of this project is to identify what is common, what varies, and what is abnormal in the human brain structure by developing a transformative brain structural network descriptor with the help of massive brain imaging data and computational model. The outcomes of this study are expected to have a broad and highly positive impact on public health by advancing our fundamental understanding of brain development and autism spectrum disorders (ASD), and potentially informing better interventions for ASD and other neurodevelopmental disorders.